Research Training in Anesthesia

Anesthesiology research has grown well beyond a search for drug mechanisms of action. The
expertise of anesthesiologists now extends to all aspects of perioperative care, and this competing
renewal has been written with that in mind. Our fundamental mission is to provide talented and
dedicated individuals with adequate time to delve into cutting edge research under the guidance of
highly successful mentors. Dr. Schonberger has served as the Program Director for this T32 Training
Program since 2021, and he was joined in program leadership by his close colleague Dr. Helene
Benveniste, Professor of Anesthesiology at Yale. Dr. Benveniste continues to serve as co-Director on
the proposed renewal of this post-doctoral training program which will enter its 15th year.
Our post-doctoral training program employs 5 tracks: Neurobiology, Vascular Biology,
Immunology/Inflammation, Biomedical Engineering, and Clinical Research. In this renewal, as in
previous iterations of the program, we request a total of three slots. Trainees will dedicate two-years of
between 80-100% of their work effort to research training, whether it be laboratory research, didactic
training, preparing manuscripts and grants, or attending meetings and conferences. The five tracks are
designed to provide trainees with a breadth of basic science and clinical research opportunities in areas
that are directly relevant to anesthetic practice.
Preceptors have been strategically selected and have the following qualities: i) a history of
outstanding training and mentorship – for younger Preceptors, a history of excellent interactions with
junior house staff and an exciting and clinically relevant research program are deemed sufficient for
inclusion; ii) research focus in one or more of the five selected training tracks; iii) a clear desire to train
productive clinician scientists in Anesthesiology. Preceptors with expertise across multiple scientific
areas can provide a richer and more interdisciplinary training experience, which will be profoundly
beneficial to trainees after they emerge from the T32 program to begin independent careers.
Since assuming the role of PI, Dr. Schonberger, in collaboration with Dr. Benveniste, has further
strengthened the training environment with increased frequency of scientific and social meetings for all
trainees, the creation of an external advisory board, increased collaboration with Yale’s internal Office
of Physician Scientist and Scientist Development, and a renewed focus on long-term improvements in a
diverse pipeline through recruitment of summer students through Yale’s Diversity, Inclusion,
Community Engagement, and Equity (DICE) program. To date, we are extremely pleased with the
progress of our current and former trainees, and we hope that the NIGMS will continue to support this
remarkably successful program.

Public health relevance
This competing renewal of our post-doctoral training grant in anesthesiology will prepare young physician scientists to become independent researchers in areas of medical science that are pertinent to the practice of anesthesiology and perioperative medicine. Areas of scientific focus include Neurobiology, Vascular Biology, Immunology, Biomechanical Engineering, and Clinical Research. Across all of these areas, our foundational mission is to train future independent scientists who will expand and apply knowledge of anesthesiology toward improving public health and well-being.